Expanding the Pipeline to Graduate Research in Alzheimer's Disease and Related Dementias (EPGRAD) Program

Project Summary
The proportion of Americans over the age of 65 is expected to increase over the next few decades and the
number of those afflicted with Alzheimer’s disease and related dementias (ADRD) is also expected to increase
substantially. To adequately serve this growing population, we need to make considerable progress in
understanding ADRD and in developing evidence-based practices for prevention and care. As the US
population ages, it is also becoming more racially and ethnically diverse. Despite this fact, the racial and
ethnic diversity of those focusing on ADRD research does not reflect the diversity of the population that bears
the high burden of ADRD. This is problematic, as the ability to be responsive to ADRD needs of such a
population will require culturally informed approaches and diverse investigators with appropriate knowledge
and skills. Information about and opportunities to enter the ADRD research workforce are not equally available
to all, which may be why few students from racial and ethnic minority backgrounds pursue graduate study or
careers in this area. In order to address these issues, we propose to establish a summer program and
mentorship network that expands the pipeline of students from underrepresented groups who decide to pursue
graduate study and, ultimately, careers in ADRD-related research areas. The proposed program will be jointly
administered by two world-class research institutions in two of the nation’s biomedical and public health
research hubs: George Washington University (GWU) in Washington, DC and Boston University (BU) in
Boston, MA. Faculty from GWU’s Institute for Brain Health and Dementia will work in collaboration with faculty
from BU’s Framingham Heart Study Brain Aging Program (FHSBAP) to mentor program participants as they
work on ADRD-related research projects. The program will provide structured and suitably-tailored didactic,
research, and social experiences for participants that will serve to elicit and magnify interest in ADRD research,
develop skills that will make them competitive applicants for graduate study, and provide a network of mentors
who will engage with them as they navigate the path from undergraduate to graduate study.

Public health relevance
Project Narrative The Expanding the Pipeline to Graduate Research in Alzheimer’s Disease and Related Dementias (EPGRAD) Program is an intensive two-month summer training experience for undergraduates from diverse backgrounds that will encourage students to pursue graduate study and careers in research on aging and Alzheimer’s disease and related dementias (ADRD) – thus increasing the diversity and inclusivity of the research workforce in these areas. The program will blend didactic training in epidemiological research methods and introductory data science methods with hands-on mentored research experiences in the area of ADRD. In addition to these experiences, trainees will participate in graduate school and career counselling sessions, journal club meetings, cutting-edge research seminars, and social activities that will serve to foster skills development and interest in aging and ADRD.